Determining the genetic drivers of ancestry-specific differential penetrance of APOE4 in sporadic Alzheimer’s Disease

PROJECT SUMMARY AND ABSTRACT
Alzheimer’s disease (AD) is a heritable and debilitating progressive neurological disease and the most
common form of dementia. Among the AD risk loci identified by decades of AD genetics research, the APOE
locus encoding for Apolipoprotein E, specifically the APOE4 isoform, is the strongest known genetic risk factor
for sporadic AD (sAD). Thus, APOE4 represents a prime therapeutic target. However, APOE4 is differentially
penetrant across genetically-defined ancestral populations, increasingly so across African (AFR), Non-Finnish
European (NFE) and East Asian (EAS) ancestries. This suggests that other common genetic factors may modify
its penetrance and therefore protect or predispose certain individuals to its pathological effects. Yet, the definitive
sources of these differences remain undefined. This highlights a crucial gap in our understanding of sAD
heritability that will be essential to effectively prognosticate, stratify, and treat diverse patient populations.
Recent trans-ancestry transcriptional profiling suggests that APOE4 expression in the AD brain differs
across ancestries and thus could be a key modifier of AD risk from APOE4. These expression differences could
be attributed to noncoding genetic variants within the APOE locus that influence cis-regulatory element activity,
leading to context-specific transcriptional dysregulation of APOE that drivies cell type- and state-specific
molecular phenotypes. Indeed, increased APOE expression has been linked to sAD phenotypes. Further
supporting this, reporter assays in cell lines suggest a subset of variants nearby APOE are functional. However,
it is yet to be definitively confirmed which, if any, of these APOE locus noncoding variants underlie differential
penetrance across AFR, NFE and EAS ancestries. This work aims to pinpoint functional ancestry-specific
genetic modifiers of APOE4 penetrance in human cells. Massively parallel reporter assays in iPSC-derived brain
cell types will functionally prioritize from a comprehensive set of 10,661 analytically-nominated variants (Aim 1).
Transcriptomic and epigenomic profiling of ancestry-diverse iPSC-derived brain cell types will create ancestry-
and cell type-specific gene-regulatory maps of the APOE locus necessary to functionally interpret prioritized
variants (Aim 2). In turn, employing scarless genome editing in iPSC-derived models will determine the
sufficiency of analytically nominated high-priority variants to alter gene expression in the APOE locus (Aim 3).
This proposed work will accompany training goals centered around structured coursework in
bioinformatics, leadership and management training, and improving science communication towards leading an
independent research group in the future. Presenting this work at both broad and specific meetings will foster
interdisciplinary crosstalk core to these goals. All experiments and training will be jointly guided by sponsors Dr.
Ryan Corces and Dr. Yadong Huang in the Gladstone Institute for Neurological Disease. The unique combination
of relevant scientific expertise, structured training environment, and core resources at both UCSF and the
Gladstone Institutes will provide the necessary groundwork for successful training and research.

Public health relevance
PROJECT NARRATIVE APOE4 is the strongest genetic risk factor for sporadic Alzheimer’s disease and affects some genetic ancestries more than others, yet the definitive genetic sources of these clinically-relevant differences are unknown. This proposed work employs an in vitro functional genomics pipeline to comprehensively identify causative ancestry- specific noncoding variants that putatively underlie this differential penetrance. This work will greatly enrich our understanding of genetic predisposition to sporadic Alzheimer’s disease, enabling early identification of the individuals most at risk, stratification of patients into disease-relevant subgroups, and tailored therapeutic intervention.